Support for bereaved friend and family caregivers of cancer patients

Bereaved friend and family caregivers have taken on the burden of end-of-life care for patients with cancer
who die in hospice care at home. Bereavement can be emotionally devastating, especially to those who have
put aside their own needs to support the dying individual. Supporting bereaved CGs’ emotional health and
general well-being is a critical need. The proposed pilot study will evaluate the acceptability and feasibility of a
6-week low-tech nature meditation intervention aimed at supporting bereaved caregivers’ who are in the first 6
months since the patients’ death. The intervention, based on the mutually supportive role that meditation
practices and nature have been shown to promote wellbeing, will be developed capitalizing on the strengths of
the research team’s early intervention work involving patients with advanced cancer and their caregivers. For
this single group longitudinal study, Aim 1 will focus on the development of 6 nature-based healing meditation
(NBHM) auditory modules available via the study website to facilitate bereavement (grief) recovery and
assessed on parameters of directed attention, grief, and QOL (including parameters of depression/anxiety).
The 2nd aim will then evaluate acceptability and feasibility of the 6-week program of both content and delivery
methods (numbers eligible vs. number consented; numbers consented vs. numbers completed; number of
weeks using the intervention) for the intervention modules. We will then conduct semi-structured interviews
with a small diverse representative sample of caregivers to evaluate benefits, satisfaction, and challenges in
more depth. Fifty-five home-based cancer caregivers who recently experienced the death of their patient will
be recruited from Hospice of Michigan. Testing will occur at baseline (Time 1; study week 0), at the intervention
end (Time 2; week 6), and (Time 3; study week 12). This research targets a supportive caregiver intervention
that will be flexibly delivered on-line for use at the caregiver’s convenience. Once feasibility and acceptability
for this new intervention to support bereaved caregivers are addressed, a larger scale randomized control trial
will be sought.

Public health relevance
Friend and family caregivers of recently deceased cancer patients experience acute bereavement following the death. Post death bereavement is an intense period of mourning that includes an unfolding of the grief process and is characterized by strong emotions and demands on cognitive resources to those who have put aside their own needs to support the dying patient with cancer. This research will test the feasibility and acceptability of a nature-based healing meditation (NBHM) intervention to support cancer caregivers’ during the bereavement process.